Drug Induced Liver Injury Network Data Coordinating Center

ABSTRACT
The National Institute of Diabetes and Digestive and Kidney Diseases (NIDDK) has proposed the continuation
of the Drug-Induced Liver Injury Network (DILIN). As described in the RFA, DILIN will be a network composed
of up to 5 Clinical Centers (CCs) with expertise in diagnosis and management of DILI and a Data Coordinating
Center (DCC) with expertise in the management of multicenter studies and clinical and translational datasets.
The major aim of the network study is to pursue genetic analyses to find predictive biomarkers as well as
genetic "fingerprints" useful for elucidating the pathogenesis of Drug-Induced Liver Injury (DILI) and ultimately
for developing specific means of prevention and or treatment. The Duke Clinical Research Institute (DCRI)
proposes to continue as the DCC for DILIN. In this role, we will apply our extensive experience and research
infrastructure to coordinate, support and facilitate the activities of the DILIN network. In particular, we will
attend to the following specific aims: (1) Support the network’s effort to increase recruitment productivity and
efficiency; (2) Support current and new DILIN studies including new mechanistic studies and/or trials; (3)
Provide overall network support of general DILIN functions; (4) Ensure quality assurance and continue data
management activities; and (5) Administer subcontracts with external partners including the analytical core at
the National Center for Natural Products Research.

Public health relevance
Project Narrative Liver injury due to medication or herbal and dietary supplement use is an important medical, scientific, and public health problem in the US. Drug-induced liver injury (DILI) is the most common reason for non-approval, withdrawal, and clinical monitoring by the FDA. Understanding the dynamics of this medical problem and determining its clinical and genetic determinants will ultimately allow safer medications to be prescribed to patient populations and safer supplement on the market.